Progressing the Pre-clinical development of P8 for Alzheimer's Disease

Progressing the Preclinical Development of P8 for Alzheimer's disease This SBIR competitive Phase IIB renewal application is to continue with the preclinical development of Cenna's lead peptide drug candidate, P8, to treat Alzheimer's disease (AD). There is currently no cure for the disease. The pathological hallmarks of the disease include the formation and accumulation in the brain of Aß, widely recognized to be the major neurotoxic agent in AD. Earlier therapeutic attempts at lowering total Aß production were unsatisfactory as they directly targeted the catalytic activities of ß- or γ-secretase, enzymes known to hydrolyze other substrates besides APP, many with critical cellular functions. New therapeutic approaches that can inhibit total Aß production without targeting the activities of the ß- or the γ- secretase are therefore of great interest. We have a novel technology that does not target the secretases, which has yielded a potential peptide drug candidate, P8, with the ability to inhibit the production of Aß in vitro and in a transgenic mouse model of AD. P8 is being developed as a new peptide drug for the treatment of AD. In this application we propose to build upon the substantial progress made in the last two years of Phase II funding and to continue with the preclinical development of P8. Specifically, we propose to further develop the formulation of P8 as a subcutaneous injectable drug and carry out investigative non-GLP studies that will provide a toxicological and toxicokinetic assessment of P8 in formulation in order to facilitate its movement into GLP regulatory toxicological testing, which provides a full assessment of the safety profile. Efficacy of P8 in formulation will be assessed in APP transgenic mice. Larger quantities of non-GLP, GLP and GMP grades of P8 will also be synthesized and characterized for the current proposed work and future IND-enabling toxicology and Phase 1 studies.

Public health relevance
Narrative Alzheimer's disease (AD) is a devastating degenerative neurological disorder that affects one-tenth of the population over the age of 65. There is no cure for the disease. We have a novel peptide drug candidate P8, that is active in vitro and in vivo in reducing the toxic species, Aß, that is being developed as a new disease- modifying drug for the treatment of Alzheimer's Disease. Our overall goal in this Phase IIB application is to continue with the preclinical development of P8. In this application we will further develop the formulation of P8 as a subcutaneous injectable drug and carry out exploratory non-GLP general toxicology studies in two species of animals in order to facilitate the movement of P8 into GLP regulatory toxicology studies necessary for the filing of an IND.